Molecular Mechanisms and Treatment of Primary Amyloid (AL) Cardiomyopathy

[unreadable] DESCRIPTION (provided by applicant): Primary amyloidosis (AL), the most common systemic amyloidosis in the US, is a plasma cell dyscrasia resulting in the clonal production of immunoglobulin light chain proteins and subsequent amyloid fibril deposition in multi-organ, The heart and the kidney, alone or together, are the most frequently involved organs. Cardiac involvement with congestive heart failure is the most frequent cause of death in primary amyloidosis, due to the development of a rapidly progressive cardiomyopathy, with ill prognosis, usually within months. While this disease has been identified decades ago, yet, the molecular mechanisms underlying primary amyloid cardiomyopathy remain unknown. We have recently provided the first insights into the pathophysiology of primary amyloid cardiomyopathy, challenging existing hypotheses - that cardiac dysfunction is secondary to physical infiltration of the myocardium by amyloid fibrils and demonstrating, for the first time, a direct effect of human amyloidogenic light chain proteins on cardiomyocyte function independent of amyloid fibril formation. Furthermore, our data suggest that amyloid light chain proteins induced cardiomyocyte dysfunction is through activation of specific cellular signaling pathways and generation of reactive oxygen species. These findings have provided the first mechanistic insight into primary amyloid cardiomyopathy, and have led to the generation of our central hypothesis that circulating immunoglobulin light chains directly result in cardiomyocyte dysfunction and contribute to the rapid progression of primary amyloid cardiomyopathy, independent of interstitial fibril deposition, through activation of redox-sensitive and stress-activated kinases signaling cascades, and subsequent cellular oxidant stress. Utilizing a multidisciplinary approach of cellular biology, cardiomyocyte physiology, and genetics, as well as in-vitro and in-vivo methodologies, the major goal of this proposal is to expand upon our previous findings and to determine specifically: (1) the molecular mechanisms underlying primary amyloid cardiomyopathy (Specific Aims 1 & 2) and (2) potential therapeutic targets for the treatment of primary amyloid cardiomyopathy (Specific Aim 3). The results obtained from this proposal, we hope to contribute to our understanding of AL cardiomyopathy, and thus, harness the therapeutic potential to cure this rapidly fatal disease. [unreadable] [unreadable] [unreadable]